Characterization of midbody remnant mediated cell fate decisions in autism

ABSTRACT
Asymmetric division of neural progenitor cells (NPCs) is critical for the formation of the diverse cell types
and complex architecture of the cerebral cortex. Abnormalities in this process have been consistently observed
in autism spectrum disorder (ASD), manifesting as altered NPC proliferation, dysregulation of cellular signaling
pathways, and structural changes within the cortex. These recurrent findings across ASD subtypes hint at
asymmetric NPC division as a potential mechanistic nexus in ASD pathogenesis. Yet, the common pathways
through which various ASD risk factors impact this process remain largely unexplored, obscuring the
developmental origins of ASD. Our collective aim, leveraging the collaborative efforts of the Wolter and Skop
labs, is to unearth causal molecular mechanisms driving neurodevelopmental alterations in ASD. Our recently
published preliminary data introduces a novel form of intercellular communication implicated in ASD: the
transfer of genetic material via midbody remnants (MBRs). Contrary to past beliefs, these large extracellular
vesicles are now recognized for their role in cell fate determination, facilitated by the transfer of cell-type-
specific mRNAs. Our data suggests an accumulation of MBRs laden with ASD risk gene mRNAs in the
proliferative zones of the developing human cortex, suggesting that MBR dynamics may influence cortical
development in ASD. This proposal aims to elucidate the impact of MBR-mediated genetic information transfer
on the cortical cellular composition in the context of an ASD linked mutation (PTEN(+/-)). We hypothesize that
PTEN haploinsufficiency alters the molecular composition of MBRs, influencing NPC proliferation and neuronal
differentiation. Aim #1 focuses on determining how an ASD-associated PTEN mutation alters MBR molecular
landscape, utilizing RNA sequencing and cell surface proteomics in PTEN(+/-) iPSC lines during neural
differentiation. Aim #2 examines how MBR uptake influences cell division and neurogenesis in PTEN(+/-) cortical
organoids, employing mosaic organoids and a novel reporter system to trace MBR autonomous effects. By
addressing the unknowns of how transfer of genetic information via MBRs affects cortical development in ASD,
this research promises to pioneer a new investigative path in ASD research, setting the stage for subsequent in-
depth studies on MBR's molecular mechanisms in ASD.

Public health relevance
PROJECT NARRATIVE Changes in the cellular composition, organization, and connectivity of the cerebral cortex is a consistent characteristic of many autism subtypes, yet the molecular and developmental mechanisms underlying these changes are largely unknown. Here we propose a series of experiments testing a novel hypothesis in autism; intercellular transfer of genetic material by neural progenitor cells affects the cellular landscape of the developing human brain. If supported, this hypothesis will inform a mechanism of intercellular communication that is especially relevant to the underlying molecular and cellular changes in the developing brain in autism.